MITRAL REGURGITATION AFTER MYOTOMY-MYECTOMY IN HYPERTROPHIC CARDIOMYOPATHY

We described 3 patients with hypertrophic cardiomyopathy who after septal myotomy-myectomy had severe mitral regurgitation. All 3 patients had complete relief of the left ventricular outflow obstruction by the myotomy-myectomy operation but nevertheless, severe symptoms of cardiac dysfunction persisted post-operatively. At reoperation, ruptured mitral chordae tendineae were found in 2 of the 3 patients and severe posterior leaflet systolic anterior motion in the third patient. It is likely that the mitral valve damage was done at the time of the myotomy-myectomy operation. Thus, this potential danger must be kept in mind at the time of myotomy-myectomy in these patients.